RADIOIMMUNODETECTION &RADIOIMMUNOTHERAPY OF CANCER

This grant application seeks financial support for a Fourth Conference on Radioimmunodetection and Radioimmunotherapy of Cancer, to be held in Princeton, NJ, September 17-19, 1992. This conference has been occurring every 2 years since 1988, and represents the only meeting of its kind which handles, in depth, all relevant topics concerning the use of radiolabeled antibodies for imaging and treatment of cancer. These topics include: radiochemistry of antibodies, physics and dosimetry of radiolabeled antibodies, radiation biology, experimental studies of targeting with monoclonal antibodies, clinical studies of radioimmunodetection of cancer, experimental and clinical radioimmunotherapy, reengineering of monoclonal antibodies and new approaches to monoclonal antibodies. In addition to plenary sessions of invited speakers, short communications and posters will be included in the conference. At the conclusion, each session chairman will summarize the advances and problems of the topic covered. The proceedings of the conference will be published as a supplement to a major cancer immunology/radiopharmacy journal such as Cancer Research, within one year of the meeting.